U-RISE at the New Jersey Institute of Technology

Project Summary/Abstract
Developing a skilled biomedical workforce is critical for future economic and societal success.
The New Jersey Institute of Technology (NJIT) is a public university with a focus on STEM
education. As an R1 research-active university, NJIT’s vision is to provide undergraduate students
with research training and mentorship to produce the future generation of scientists and
engineers. This training proposal aims to combine the strengths of the NJIT Biomedical
Engineering, Biological Sciences and Chemistry and Environmental Science Departments to
support seven undergraduate students per year to participate in a three year biomedical research
immersion program. NJIT draws students from over 100 countries and conducts extensive
outreach to women and underrepresented populations in STEM disciplines, ranking in the top 20
of campus ethnic diversity. Embracing the diversity of students at NJIT, this program will
emphasize the training of underrepresented groups, with the goal of increasing participation in
research and the transitioning to graduate programs. This program will augment NJIT’s existing
culture of inclusivity, engaging students from all racial backgrounds, national origins, gender
preferences and abilities. Program Training Objectives: To accomplish our mission, the program
intends to: 1) increase the number of fellowship-supported UG students committed to finishing a
Bachelor’s Thesis 2) increase the number of underrepresented groups in research through
engagement in self-directed learning-based research experiences, 3) retain trainees for the 3 year
training period and graduate within the predicted time to graduation 4) foster science and
engineering identity through asset-based individualized research experiences, 5) increase the
number of students who choose to pursue a research-focused higher degree program in a
biomedical field, and 6) enhance the visibility and competitiveness of NJIT trainees in the
biomedical field. Our overall training approach will be based on the Staged Self-Directed Learning
model as a framework for a structured training program to assist students to grow into self-directed
learners. The program comprises didactic training, career development activities, individualized
mentorship, and two semesters of research for credit culminating in an undergraduate thesis and
scientific dissemination. As an urban technological university serving one of the most ethnically
diverse populations in the country, we hope to utilize this training program to prepare a competitive
cohort of undergraduate students who, as future scientists and engineers, would help diversify
the field of biomedical research.

Public health relevance
Project Narrative The New Jersey Institute of Technology (NJIT) is an R1 research-active public university with an educational mission of providing students with research training and mentorship to produce the future generation of scientists and engineers. The goal of this training proposal is to develop a 3 year biomedical research immersion program, focusing on engaging students from all racial and ethnic backgrounds, national origins, gender preferences and abilities. The intended outcomes are to establish a didactic multidisciplinary research training program integrated with academics, enhance the diversity of participation in research, increase competitiveness of trainees, and through successful mentorship, encourage students to consider an academic or professional degree in the biomedical field (i.e. PhD, MD/PhD).